ACTG 219--MULTICENTER TRIAL OF THE AIDS CLINICAL TRIALS GROUP

The purpose of this study is to follow children who are currently enrolled in or were previously enrolled in pediatric ACTG treatment or drug research studies to look for any late consequences of therapy in growth, neurologic and neuro-psychologic function, long-term survival and quality of life.